ROLE OF BETA ADRENERGIC SENSITIVITY ON HYPOGLYCEMIA UNAWARENESS SYNDROME

To study the role of beta adrernergic sensitivity on hypoglycemia unawareness syndrome in type I diabetics. This is currently a data analysis only protocol.